Administrative Core

ORDRCC Administrative Core Project Summary
The Oklahoma Rheumatic Disease Research Cores Center (ORDRCC) facilitates collaborative rheumatic
disease research, provides cutting-edge technologies to address new clinically-relevant questions, recruits
investigators with other interests/training to rheumatic disease investigation and fosters development of junior
investigators to independent rheumatic disease research careers. With 25 local Center Investigators, 11 Junior
Center Investigators (local), 11 Junior Center Investigators (distant) and a new Scholar program to develop
early stage investigators committed to rheumatic disease investigation, the ORDRCC Administrative Core
serves as the central communications hub and information conduit to accomplish the expanded ORDRCC
mission to provide detailed, individualized information for each study patient to allow investigators to select
homogeneous, mechanistic-driven subsets of patients for studies of pathogenesis, prediction, prevention and
precision treatment of SLE, Sjogren’s, UCTD and related disorders. The ORDRCC will enhance the career
development of junior investigators and expand rheumatic disease research through a multi-pronged
Rheumatic Disease Clinical Research Enrichment Program which includes a weekly seminar series, visiting
lectureships, and a new Expanding Rheumatic Disease Colloquium held in conjunction with a new group each
quarter to explore new areas of collaborative research, such as with the Reynolds Center on Aging, OU
Bioengineering, Dean McGee Eye Institute, and others. Additional outreach communication to community-
based partners and tribal communities is also planned. The Administrative Core will enhance communication
through new online resources, listserves and updates; provide management through developed policies and
procedures for oversight and optimization of resource utilization, prioritizing service to junior center
investigators and Scholars; and develop a new Proposal Development Center within the Administrative Core to
help junior center investigators and Scholars to prepare and submit manuscripts and competitive grant
applications. The Core also assists Junior Center Investigators and Scholars with regulatory compliance
oversight. The ORDRCC has a historically vibrant pilot project program which has launched the independent
careers of 16 junior investigators who have gone on to receive over $20M in independent external grant
support. This Core will continue to offer this program which couples modest financial support with prioritized
Core resources, focused mentoring and a career development plan. The Administrative Core also serves as
the nidus for interactions with the Advisory Committee to ensure that suggestions are reviewed and
implemented. The ORDRCC has implemented a rigorous qualitative and quantitative tracking and evaluation
program evaluation which helps to monitor and maximize resource utilization and scientific discoveries. These
qualitative surveys also help to set strategic Center priorities, prioritize phenotyping services and new
technologies to evaluate and identify the patient collections which need expansion or further enhancement.